SORL1 and its involvement in Alzheimer's disease pathogenesis and pathophysiology - Project 2

PROJECT 2 SUMMARY
Alzheimer’s disease (AD) is poised to become the third leading cause of death in much of the developed world,
and is the only major cause of death for which no preventive or disease-modifying treatment exists. If none is
found, AD will cost the U.S. a trillion dollars annually by 2050. About 10% of all cases of AD are genetic and only
4 truly causal genes have been identified: APP, PSEN1, PSEN2, and SORL1. Of these, SORL1 is the only one
that causes late onset AD that phenocopies the common sporadic disease. SORL1 encodes a huge, 2214-
residue type I transmembrane protein that has at least 24 distinct domains. Its function in neurons is to help
traffic cargo proteins to their correct destinations once they are endocytosed. To do this it forms a specific
complex with cargo and with the retromer multiprotein assembly that is the master regulator of trafficking out of
the early endosomes. Mutations in SORL1 either directly cause familial AD, are significant risk factors for the
development of sporadic AD, or are relatively benign, depending on the variant. The effect of the pathogenic
mutations seems to be to cause endosomal traffic jams, which ultimately lead to the degeneration of the neuron.
Since pathogenic SORL1 mutations are involved in at least 2% of all AD cases, it is very important to be able to
determine if a given mutation is pathogenic, and if the afflicted patient will be a candidate for therapy aimed at
normalizing trafficking out of the endosome. The Program Project of which this Project is a component has as
its goal the ability to validate SORL1 mutations for pathogenicity based on their effects on SORL1 structure,
biochemical function, cell biology functions, and overall phenotypes.
Project 2 will support the overall Program Project by defining cellular sorting defects for a pre-selected set of
predicted pathogenic variants, and quantify impact on SORL1 maturation, cell surface expression and shedding,
and endosome sorting of validated cargo proteins. As some mutant protein is completely or partially retained in
the endoplasmic reticulum of the cell, a key purpose of the project is to establish how such mutant protein may
induce any unfolded protein response and elicit ER stress, as well as how partially misfolded receptor may still
enable dimerization with non-mutated SORL1 and thus act as dominant negative pathogenic variants. These
different effects may serve to subtype pathogenic variants and be unique for the different regions of the SORL1
gene that mutations occur. One of the main goals of the Project is to establish the endosomal interactome for
SORL1, as defined by the functional SORL1 dimer in complex with Retromer. Importantly, this will be pursued
for both neuronal and glial cell types.
This information will be incorporated, along with cell biology, human genetics and mouse model data from the
other Projects and Cores in the Program Project, to determine if the predicted genetic variants can be confirmed
as pathogenic, and establish the parameters of SORL1 trafficking that distinguish pathogenic variants that leads
to AD from non-pathogenic variants compatible with neuronal and endosomal fitness of the healthy aging brain.